Administrative Core

The Administration Core will manage the overall operation of the Center through the following specific functions: 1. Administrative/fiscal management 2. Scientific coordination/oversight 3. Research training and career development

Public health relevance
The Administration Core manages the overall operation of this COBRE.